HLA-E and NKG2A define a novel immune checkpoint axis in non-muscle-invasive bladder cancer

Bladder cancer is the most expensive cancer per capita to treat in the US. Non-muscle invasive bladder cancer
(NMIBC) which accounts for 70-75% of all newly diagnosed tumors and has only a single FDA approved first-
line treatment option, Bacillus Calmette-Guérin (BCG). BCG has been the only approved first-line therapy for
intermediate and high-risk NMIBC for more than 40 years. While BCG can induce durable responses, ~50% of
patients have recurrence or progression of their disease. The current dosing of BCG is arbitrary with no data
currently available to support the dosage, strain nor regimen. Furthermore, no clear mechanism of action behind
BCG’s anti-neoplastic activity in NMIBC has been delineated. Better understanding of the immune response
initiated by exposure to BCG and how such response is sustained over many repeated doses is essential to help
improve its therapeutic action. Further, it may lead to discovery of predictive biomarkers and novel targets leading
to advance care for patients, reduce the financial burden associated with the disease, and improve access to
BCG. Our preliminary data have identified a significant Type-1 cytokine response to BCG in all patients inducing
an activation and recruitment of IFN-g producing NKG2A+ natural killer (NK) cells and NKG2A+PD-1+ CD8 T cells
to the tumor microenvironment (TME). Our preliminary analyses of post-BCG-treated specimens demonstrate
IFN-g signaling as the most upregulated signature in BCG resistant specimens and strongly correlates with
increased HLA-E and PD-L1 expression on the recurring tumors. Monalizumab (anti-NKG2A) is a novel
therapeutic target and is currently in clinical trials across several cancer types. A role for NKG2A/HLA-E alone
or in conjunction with PD-1/PD-L1 in regulating NK and CD8 T cells remains elusive with virtually nothing known
in bladder cancer. Our hypothesis is that chronic activation from repeated exposures to BCG drives immune
dysregulation followed by functional exhaustion in a significant proportion of patients, which then leads to disease
recurrence or progression. The immune dysregulation in the TME is driven by NKG2A/PD-1 on CD8 T cells,
NKG2A on NK cells and HLA-E and PD-L1 on tumor cells. To further validate our findings and better understand
BCG mechanisms we will study the following aims: Aim 1: To analyze intratumoral NK cells and T cells and their
interactions with tumors in response to BCG therapy. We will test the hypothesis that upregulated expression of
HLA-E and PD-L1 on recurring tumors are directly in contact with infiltrating NKG2A+ NK and NKG2A+ PD-1+
CD8 T cells. Aim 2: To longitudinally assess blood and tumor phenotypes and functions in response to BCG
therapy. We will test the hypothesis that repeated exposures to BCG drives prolonged activation and
dysregulation of NKG2A+ NK and NKG2A+ PD-1+ CD8 T cells. Aim 3: To determine the effects of combination
PD-L1 and NKG2A blockade on anti-tumor immunity. We will test the hypothesis that NKG2A+ NK and NKG2A+
PD-1+ CD8 T cells can be functionally restored through use of PD-L1 and NKG2A combination blockade.

Public health relevance
Approximately half the patients treated with BCG, the only approved immunotherapy for non-muscle invasive bladder cancer, experience a recurrence or progression of the disease. Our goal is two-fold: First, to better understand the longitudinal local and peripheral immune response to repeated intravesical BCG exposures and second, to identify specific genetic and immunological factors that impact patients’ sensitivity or resistance to treatment with BCG. When successful this information will help identify potential new strategies for improving treatment with BCG as a single therapy or in combination with other immunotherapies.